Mechanisms of hypervirulent Klebsiella pneumoniae gastrointestinal colonization and dissemination

Parent Project Abstract.
Hospital-acquired infections (HAI) resulting from the transmission of drug-resistant pathogens affect hundreds
of millions of patients worldwide. Klebsiella pneumoniae (Kpn), a gram-negative bacterium, is notorious for
causing HAI, with many of these infections difficult to treat as Kpn has become multi-drug resistant.
Epidemiological studies suggest that gastrointestinal (GI) colonization of Kpn is a major reservoir through
which Kpn can cause disease manifestations either in the colonized host or transmit from host to host. This site
of Kpn colonization has not been the focus of previous studies as a tractable model of Kpn GI colonization, and
host-to-host transmission did not exist. We have recently developed a murine model that allows for the study of
Kpn mucosal (oropharynx and GI) colonization, shedding within feces, and transmission through the fecal-oral
route. Using an oral route of inoculation and fecal shedding as a marker for GI colonization, we show that Kpn
can asymptomatically colonize the GI tract of immunocompetent mice and modifies the host GI microbiota. We
premise that specific Kpn genes contribute to its GI colonization, and the products of these genes could serve
as novel targets for the prevention of the establishment of GI colonization. More recently, we used our murine
model to screen a library of Kpn random transposon mutants (In-seq) to identify the complete set of “GI
colonization” genes from a single isolate. A metagenomics sequencing analysis further identified bacterial
species and the metabolic pathways affected by Kpn in the GI tract. Herein, we will focus on two sets of
pathways identified through In-seq whose products allow Kpn to overcome colonization resistance provided by
the resident gut microbiota. Thus, in Aim#1, we will focus on the ethanolamine utilization pathway genes (eut)
of Kpn that allow it to utilize ethanolamine (EA), a byproduct of cellular membranes and diet in the gut that can
serve as an alternative nutrient source. Unlike many other enteric pathogens that contain a single eut operon,
Kpn has two genetically distinct eut operons. We will identify the role of each eut locus in EA metabolism and
determine the underlying molecular mechanism through which EA metabolism provides Kpn with a fitness
advantage against members of the microbiome. Aim#2 will take a different approach by focusing on the
contact-dependent killing machinery of the Kpn (Type 6 secretion system [T6SS]) in overcoming colonization
resistance provided by the resident microbiota. We will focus on the unique regulatory mechanism that
modulates the expression of Kpn T6SS in the GI tract and provide it with a selective and competitive
advantage against the resident gut microbiota. Results from these studies would provide us with a fundamental
understanding of the molecular mechanisms involved in the establishment of GI colonization by an incoming
pathogen. These studies will also lay the groundwork for developing potential strategies to reduce the Kpn
disease burden.

Public health relevance
PROJECT NARRATIVE Hypervirulent Klebsiella pneumoniae (hvKP) is an evolving pathotype that causes increased morbidity and mortality in healthy individuals within a community setting. This project will examine bacterial mechanisms, host-barrier efficacy, changes in bacterial populations, and identify bacterial genetic determinants that enable hvKP to colonize and disseminate from the gastrointestinal tract causing disease. Completion of the proposed work will aid in broadening our understanding of hvKP pathogenesis and identify potential therapeutic targets.